Investigating the Ferrostatic Role of Adipose Tissue Macrophages

PROJECT SUMMARY
Iron is a micronutrient that is essential for nearly every living organism, and maintaining its homeostasis
therefore represents a crucial biological problem across all scales: from cells, to tissues, to the whole organism.
We propose that central regulation of local iron supply in the adipose tissue is controlled by VAMs (vasculature-
associated macrophages), which are resident tissue macrophages that associate closely with the vasculature
and perform several key homeostatic maintenance functions within the tissue. While VAMs and other tissue
macrophages have been historically linked to host defense/innate immunity, there is a major gap in our
understanding of their diverse functions beyond immunity, and how their dysfunction drives the progression of
chronic inflammatory diseases such as type 2 diabetes. Gene expression profiling indicated that VAMs express
an array of genes involved in iron handling, including iron import, export, processing, and storage. Our
preliminary data shows that VAMs take up significant amounts of transferrin - the main iron carrier in blood serum
- and also serve as an iron storage depot by housing significant amounts of intracellular iron. Together, we
hypothesize that VAMs are the main regulator of white adipose tissue iron content, constantly
monitoring the demand and controlling the local supply of iron to other cells.
This study aims to elucidate the tissue-level iron handling functions of VAMs by 1) Identifying the primary
iron uptake pathway in VAMs. 2) Ascertaining the role of VAM-mediated iron export and storage in regulation of
adipose tissue iron content and systemic metabolism. 3) Uncovering the molecular mechanisms for adaptation
of adipose tissue cells to perturbations in local iron availability. To answer these questions, we developed novel
mouse models that target tissue-resident macrophages with very high specificity, thus overcoming a major
barrier that currently exists in the myeloid field. This study will advance our understanding of the multifaceted
roles of our immune system beyond immunity, with a focus on achieving deep mechanistic understanding of
macrophage-mediated support of tissue physiology and specifically of tissue-level iron homeostasis. It may
inform the biology of several diseases characterized by iron dysregulation, including type 2 diabetes,
hematological and neurological disorders, and cancer. The results of this work may influence the development
of treatments aimed to restore the proper cellular functions of dysregulated resident macrophages. This is a
dissertation project which will be conducted in the lab of Dr. Hernandez Moura Silva at the Ragon Institute of
Mass General, MIT, and Harvard, which has all the necessary facilities to perform the experiments described
and provides an excellent training environment for the investigation that spans across the fields of immunology,
physiology, and biochemistry. The proposed training plan will strengthen the candidate’s preparation to a career
in research & development in an industrial sector, where interdisciplinary skills are essential.

Public health relevance
PROJECT NARRATIVE Resident tissue macrophages have recently emerged as essential accessory cells that support proper physiology and metabolism of the tissues they reside in. While the role of these cells in systemic iron homeostasis is well known, whether and how they support iron homeostasis at the level of individual tissues is still unclear. This project aims to dissect the mechanisms by which resident tissue macrophages maintain iron homeostasis within the white adipose tissue, with the ultimate goal of highlighting their often overlooked contribution to organ physiology, which in turn may shed light on the role of iron in initiation and progression of type 2 diabetes and other disorders.